Cord Blood T Cell Therapy for Myeloid Malignancies

PROJECT SUMMARY
Acute myeloid leukemia (AML) is susceptible to immunotherapy as evidenced by the success of allogeneic
(allo) stem cell transplantation (SCT) in this disease. Although allo-SCT can be curative in leukemia, it carries a
high rate of treatment-related mortality and morbidity. This is primarily a result of off-target immune responses
elicited by donor-derived cytotoxic T cells (CTL) within the SCT graft against normal tissues, a phenomenon
known as graft-versus-host disease (GvHD), which occurs in up to 50% of patients following allo-SCT.
Furthermore, AML relapse remains the leading cause of mortality following allo-SCT, highlighting the shortfalls
of allo-SCT in providing long-lasting cures. In order to minimize GvHD, while taking advantage of the graft
versus leukemia (GvL) effect, numerous leukemia-associated antigens (LAAs) have been identified and shown
to elicit leukemia-specific immune responses. PR1 is an HLA-A2-restricted LAA that we identified in our lab
and targeted using a monoclonal T cell receptor (TCR)-like antibody (8F4), a PR1-peptide vaccine, and PR1-
CTL. In the current proposal, we plan to engineer chimeric antigen receptor (CAR) T cells that target PR1/HLA-
A2 on the surface of AML using the 8F4 construct. The rationale for this proposal is that in view of the
shortcomings and significant toxicities associated with allo-SCT, balanced by the susceptibility of AML to
immunotherapy (i.e. allo-SCT), there is a critical need to develop novel immunotherapies to achieve disease
elimination with minimal off-target toxicity. We plan to use 8F4 as the CAR since it has a very high affinity for
the PR1/HLAA2 epitope presented by AML. We plan to use cord blood T cells as the cell source for
engineering the 8F4-CAR T cells due to the success we have recently encountered in engineering and
expanding sufficient numbers of effective 8F4-CAR T cells using cord blood products. Furthermore, we showed
potency of the cord blood-derived 8F4-CAR-T cells in treating human AML in a mouse xenograft model. We
will also introduce a caspase 9 (iCP9) suicide gene into the CAR construct, to increase the safety profile of the
8F4-CAR-T cells. Our central hypothesis is that immunotherapy with iCP9-8F4-CAR T cells engineered from
cord blood T cells will eliminate PR1-expressing AML, with minimal off-target toxicity. We will (1) validate the
safety and anti-leukemic activity of the iCP9-8F4-CAR-T cells in animal models using primary patient AML
samples and cell lines; (2) test the safety and efficacy of the iCP9-8F4-CAR-T cells in patients with AML as a
bridge to allo-SCT; and (3) study immune reconstitution and perform correlative studies using blood and bone
marrow samples from iCP9-8F4-CAR-T cell recipients. After completion of our proposed studies, we anticipate
that PR1-targeting adoptive cellular therapy using 8F4-CAR-T cells could become a standard therapy for
patients with myeloid leukemia. In addition, our studies will elucidate the potential for cord blood T cells in the
engineering of CAR-T cells for the treatment of cancer.

Public health relevance
NARRATIVE Chimeric antigen receptor (CAR) T cells have shown promise in the treatment of leukemia. We have identified PR1 as a myeloid leukemia antigen and have engineered immunotherapies that target PR1 including a T cell receptor-like monoclonal antibody (8F4), cytotoxic T lymphocytes (CTL) and a peptide vaccine. We propose (1) to engineer CAR T cells from cord blood T cells using 8F4 as the CAR construct and (2) to treat patients with AML/MDS with 8F4 CAR T cells as a bridge to allogeneic stem cell transplantation.